Improving Strategies to Determine Pathogenicity of Variants of Uncertain Significance

PROJECT SUMMARY / ABSTRACT
The application proposes a four-year mentored research and training experience crafted to advance the
candidate’s career as a leader in genomic medicine. The candidate earned a combined MD/PhD in Molecular
and Human Genetics and is board certified in Pediatrics. His long-term career goal is to become an
independently funded physician-scientist at a major academic center and to advance research efforts that
integrate translational genomics with innovative strategies to determine pathogenicity of missense variants
currently categorized as variants of uncertain significance (VUS). The proposed work leverages skills he
developed during prior training and research and will form the basis for a successful R01 proposal. The career
development plan includes milestone-based training in biomedical informatics (including the conferring of a
Master’s degree), statistics, and the design and implementation of functional genomics experiments. The
candidate will receive training in ethical and responsible conduct of research, communication skills, grant
writing, and laboratory management via participation in core curricula, workshops, seminars, laboratory
meetings, and local, national, and international presentations. The mentoring team for the proposed
interdisciplinary project includes expertise in clinical, statistical, computational, and functional genomics. The
primary mentor, Dr. Barak Cohen, is an experienced mentor and an expert in experimental and computational
approaches for functional genomics evaluations. The co-mentors, Drs. Michael Province, Christina Gurnett,
and David Ledbetter, each bring unique expertise and commitment to the candidate’s success. Additional
members of the mentorship advisory committee include the long-term mentors of the candidate, Drs. F. S. Cole
and John Constantino, and the neurofibromatosis expert, Dr. David Gutmann. Washington University School of
Medicine (WUSM) provides an exceptional research and training environment, including resources from the
McDonnell Genome Institute and the Institute for Informatics. The candidate has the full support of the
Department of Pediatrics, which has a long history of training physician-scientists. The research proposed
addresses a central problem in human genetics today, namely variant interpretation. This work will integrate 1)
deep mutational scanning and experimental validation to determine pathogenicity of missense variants
currently categorized as variants of uncertain significance (VUS), and 2) exome sequencing and linked
Electronic Health Record data from >90,000 individuals for clinical validation. The well-studied NF1 tumor
suppressor gene will serve as a model for developing best practices for variant interpretation. The work will
directly impact the assessment and care of patients with NF1-related diseases and will serve as a template for
generating similar models for a range of diseases. The candidate, his mentors, the Department, and WUSM
are committed to his becoming an independent physician-scientist and leader in genomic medicine.

Public health relevance
PROJECT NARRATIVE Changes in DNA can cause genetic disease, but because each person has many changes, it can be difficult to predict which changes are disease causing or not. This work combines large-scale information from thousands of research subjects and data from high throughput experiments in the laboratory to help improve these predictions, so that more patients can be appropriately diagnosed. This research can give a family answers to the question of why their child has a genetic disease and lead to better predictions of whether the genetic disease will re-occur.